Effect of Age, Sex, and Injury on Regional Stresses and Resulting Growth of the Anterior Cruciate Ligament

PROJECT SUMMARY
Pediatric anterior cruciate ligament (ACL) injuries and surgical intervention rates are rapidly increasing in recent
years. Of particular concern, pediatric patients are approximately five times more likely than adults to experience
a secondary ACL injury after surgical reconstruction. Further, sex plays a factor in injury rates, where females
experience a higher risk of ACL injury than males during adolescence, but not childhood or adulthood. However,
the mechanism of ACL injuries and the reasons behind these age and sex-related differences remain unclear.
This is, in part, due to difficulty experimentally observing the ACL during injury and limited data regarding the
function of the ACL and its anteromedial (AM) and posterolateral (PL) bundles throughout skeletal growth. ACL
injuries likely occur when the ligament experiences high local stresses—forces concentrated over a small area.
Preliminary data from our group has shown sex-dependent growth and function of the AM and PL bundles, so it
seems likely that sex and age will impact the magnitude and location of local stresses within the ACL. Therefore,
the objective of this proposal is to determine how age and sex impact local stresses in the ACL throughout
skeletal growth and how partial ACL injury may affect growth and remodeling of the remaining portion of ACL
and other tissues in the knee joint. Aim 1 will assess how sex and age impact regional stresses experienced in
the AM and PL bundles of the ACL under applied loads. Aim 2 will assess how regional stresses change as an
immediate effect of partial injury. Aim 3 will assess how long-term changes in tissue and knee joint mechanics
after partial ACL injury impact growth and remodeling of the remainder of the ACL and surrounding cartilage.
These aims will be accomplished by developing experimentally validated subject-specific FE models to simulate
mechanical loading of the ACL in males and females at different stages of skeletal growth. Additionally, the long-
term impact of partial ACL injury will be investigated in vivo using the porcine model. Growth and remodeling will
be studied non-invasively using quantitative imaging techniques and computational simulations of growth in
response to regional tissue stresses.

Public health relevance
PROJECT NARRATIVE Anterior cruciate ligament (ACL) injuries are becoming increasingly common in children and can have long lasting impacts on patients’ quality of life. This research will investigate the effect of age and sex on regional stresses experienced in the ACL under applied loads in healthy and injured conditions, and the long-term effect of partial ACL injury on growth and remodeling of the remaining bundle of the ACL. The outcomes of this study could help to explain age and sex-dependent ACL injury rates and locations and be used inform clinical treatment strategies of pediatric ACL injuries.